Ischemic Brain Damage and Single Quantum Sodium MRI

PROJECT SUMMARY
This proposal seeks to evaluate the role of tissue sodium concentration (TSC), as measured by magnetic
resonance imaging (MRI), on the acute management of brain ischemia. To achieve this goal, we will perform
MRI scans within 20 minutes of recanalization therapy on acute stroke patients treated in the Interventional
Neuroradiology service at the New York University School of Medicine (NYUSOM). Our underlying hypothesis
is that brain tissue with a TSC above 65mM represents non-viable tissue and, therefore, will not recover upon
reperfusion therapy of any type. This hypothesis was borne out from observations during our previous work on
serial MR imaging during reversible middle cerebral artery occlusion of non-human primates. This hypothesis
will be tested by comparing the spatially co-registered volume of critically elevated TSC (above 65mM) after
recanalization and the volume of infarction (on the 30 day follow up) on the brain of each study subject. We
plan to enroll a total of 120 subjects during this five-year proposal in order to account for the heterogeneity of
the disease while still attaining the required statistical significance.

Public health relevance
PROJECT NARRATIVE The goal of this project is to investigate the role of a new MRI technique, sodium MRI (sMRI), during the acute management of stroke patients. Currently, we lack brain scans to unambiguously decide which patients could benefit from clot-removal therapies. The proposed work is aimed at evaluating if sMRI scans could provide this critical information.